Function of LRP1 in regulating Aβ clearance in choroid plexus.

This application corresponds to Notice of Special Interest: Alzheimer’s-focused administrative supplements for
NIH grants that are not focused on Alzheimer’s diseases. Alzheimer’s disease (AD) is a progressive
neurodegenerative disorder that is characterized by memory loss, impaired cognition and eventual functional
disability and death. AD affects an estimated 5.8 million people in the United States with half a million new cases
annually, and this number is anticipated to more than double within 30 years. Given the significant increase in
the prevalence of AD in the adult populations, identification of novel targets for treating and preventing AD and
its related dementias is urgently needed. The hallmark of AD pathogenesis is the accumulation of amyloid-
peptide (A) plaques between nerve cells in the brain. The A accumulation is the result of an imbalance of A
generation in amyloid precursor protein and its subsequent clearance. Impaired A clearance is predominantly
responsible for its accumulation in sporadic or the late-onset AD rather than A overproduction. The low-density
lipoprotein receptor-related protein-1 (LRP1) is found to play a pivotal role in eliminating A in the brain by
promoting A uptake and degradation in astrocytes, neurons and cerebrovascular smooth muscle cells, and A
transcytosis across the blood brain barrier. Along with this, it has been reported that A is rapidly removed via
LRP1 in rat choroid plexus epithelial cells in vitro. However, a major gap in understanding the central
mechanisms underlying LRP1-mediated A clearance has been a lack of knowledge regarding how LRP1
regulate A elimination in the choroid plexus (ChP). This is due to a lack of an appropriate animal model that
can study LRP1’s function in the ChP in the context of A clearance in vivo. During the research period of the
parent grant (R01DK12302, Control of leptin transport system by LRP), we have generated the mice lacking
LRP1 in the epithelial cells of the ChP by breeding LRP1loxP/loxP with Ttr-Cre mice (Ttr-Cre; LRP1loxP/loxP). We have
also created a conditional LRP1 overexpression knockin mouse model (lox-LRP1-KI). Using these models, we
will test the novel hypothesis that LRP1 in the epithelial cells of the ChP is an indispensable regulator of A
clearance from the brain to circulation and dysfunction of LRP1 in the ChP causes A accumulation in the brain,
leading to AD. To this end, we will determine whether deleting LRP1 in the epithelial cells of the ChP blocks A
transport from the brain to the bloodstream in mice. We will further determine whether overexpressing LRP1 in
the epithelial cells of the ChP promotes A clearance from the brain to the bloodstream in mice. The data
generated from these studies may offer further insights into the pathogenesis of AD-related disorders and lead
to new therapeutic targets for the treatment of AD.

Public health relevance
The hallmark of Alzheimer’s disease pathogenesis is the accumulation of amyloid- peptide (A) plaques between nerve cells in the brain, and the cause of this is not fully understood. The A accumulation could be the result of an imbalance of A generation from amyloid precursor protein and its subsequent clearance. This proposal will uncover the key route of brain-derived A clearance that could contribute to better understanding the etiopathogenesis of Alzheimer’s disease and its related dementias.